Biocatalytic C-H Activation for Enantioselective Carbon-Carbon Bond Formation

Project Abstract/Summary There are no changes from the original document.

Public health relevance
Project Narrative There are no changes from the original document.